Training Program in Social Environments and Population Health

PROJECT SUMMARY/ABSTRACT
(copied from parent grant)
The Population Research Institute (PRI) and Graduate Program in Demography at the Pennsylvania State University
request a five-year renewal of our NICHD T32 training program in population studies, with a focus on Social
Environments and Population Health. We request support for 5 predoctoral and 2 postdoctoral training slots for
each year of our grant. This is an increase from 4 predoctoral and 1 postdoctoral trainees from our last application because
we have expanded the number of participating faculty members in this training effort from 29 to 36 and participating
academic programs from 3 to 6 due to new faculty hires and new connections across the university. We draw upon the
strengths of our innovative, multidisciplinary, dual-degree Ph.D. Graduate Program in Demography; other participating
programs, including Sociology, Human Development and Family Studies, Anthropology, Rural Sociology, and Health
Policy and Administration; and the Population Research Institute (PRI). This combination makes Penn State a center of
excellence for multidisciplinary research and training in population health. The proposed predoctoral program integrates
strong training in demography (demographic theory, methods, and fertility, health/mortality, and migration) with
population health perspectives and methods from several programs. The postdoctoral program likewise is focused on
enhancing research and training in social environments and population health. Predoctoral trainees are recruited from the
approximately 263 annual applicants to, and students currently enrolled in, the five participating academic departments
that partner with the signature Dual Degree program in Demography. Over the past ten years of our T32 grant, 100
percent of NICHD pre- and postdoctoral trainees have either been awarded their dual-degree Ph.D. in Demography or
completed their program, or are currently enrolled and on track to successfully complete their program. Of the 30
previously appointed trainees who graduated, 87 percent are currently working in research or research-related fields,
or pursuing further research training. Our trainees have moved into positions in academia, government, and research
and policy organizations, where they continue to produce high quality research and publications, and influence national
programs and policies that affect the health and well-being of families, communities, and nations.

Public health relevance
PROJECT NARRATIVE (copied from parent grant) The principal goal of our training program is to provide a rigorous, innovative, and multidisciplinary training program on Social Environments and Population Health that integrates research, study, and associated activities. The training program, anchored in the Penn State Dual-Degree Demography Program, the Population Research Institute, and associated departments and programs, has a long history of successfully recruiting promising predoctoral and postdoctoral candidates in the population sciences and placing them in high-impact, research-intensive positions.